Genomics and Computational Biology

The Genomics and Computational Biology Core provides a critical means by which this U19 will achieve its goal of understanding the human innate and adaptive response to Yellow Fever Virus (YFV) in the young and aged. The Core will provide expertise, computational support and novel gene expression analysis technologies to enable the experiments detailed in this proposal. The Core will be centered at Dana-Farber Cancer Institute (DFCI), a leading institution in the application of genomic technologies, and include expert computational support from the Broad Institute of Harvard and MIT, and Georgia Institute of Technology. The Core will serve two primary functions. First, it will generate genomic data using a highthroughput expression profiling platform developed by our group that allows large numbers of samples to be profiled at low cost. It will also provide training for Project sites to generate genomic data from rare populations of cells using optimized RNA amplification approaches. Second, the Core will assist the projects to provide centralized design, development and analysis of genomicbased research that is instrumental to the projects.

Public health relevance
The Projects in this U19 will rely heavily on a range of genomics technologies to interrogate the innate and adaptive response to YFV in humans. The Genomics and Computational Biology Core will provide the analytic and experimental tools that will enable the Projects to execute their proposed goals. Characterizing the human immune response to YFV will accelerate the development of molecular predictors of immunity in humans, and optimize vaccination strategies for infectious disease.